Solvent Evaporator Equipment Supplement to R35GM143101

PROJECT SUMMARY/ABSTRACT
Biodegradable polymers have demonstrated great utility for controlling the release of drugs in vivo, improving
drug efficacy, enhancing drug safety, and increasing patient adherence to medication. Unfortunately, current
polymers, such as poly(lactic-co-glycolic acid) (PLGA), are not ideal for a number of reasons, despite their well-
reported biocompatibility. These materials are generally bulk-degrading materials whose behavior must be
empirically determined and offer very little potential for tuning the shape of the cumulative drug release curve
other than simply extending or compressing first-order release kinetics. The parent award of this administrative
supplement proposal aims to develop new drug delivery systems based on surface-eroding biodegradable
polymers that enable full, predictable control over release kinetics, protect encapsulated biologics from
environmental stressors that would otherwise diminish their bioactivity, and release multiple drugs in user-
defined sequence. This effort requires the synthesis of photo-responsive surface-eroding materials, light-based
fabrication to form polymeric microstructures and, in some cases, drug loading using a polymer matrix swelling
method. Each of these steps necessitates the use of an organic solvent. Polymerization, photoinitiator
distribution, and solvent-mediated drug uptake are performed in solvents, which must be removed prior to in vitro
or in vivo evaluation. A solvent evaporator is, by far, the best tool for this job as it works with small reaction
vessels, is compatible with viscous materials, and avoids the formation of bubbles that might undermine
microparticle morphology. This tool combines the benefits of low pressure, a pre-defined temperature, and
centrifugation, which prevents bumping, allowing for the rapid recovery of material with minimal processing
losses. The alternatives to a solvent evaporator, which we have recently been forced to employ once our 15-
year-old solvent evaporator broke down, are very poor substitutes for the functionality that we lost. A rotary
evaporator can—for some polymers and organic solvents—remove the solvent; however, this requires much
longer to remove the solvent (sometimes several evaporation cycles with a co-solvent), takes far more time (one
sample in one day) to run one sample than it did to run many samples with the solvent evaporator. Additionally,
a large quantity of material is lost during transfer and evaporation, which is particularly unfortunate because of
the precious nature of our custom-synthesized, surface-eroding polymer. This proposal seeks the financial
support necessary to purchase a new solvent evaporator—an SP Genevac EZ-2.4 ELITE evaporator system.
This piece of equipment will be able to restore the function that we lost when our previous tool became inoperable
while also enhancing our capabilities by enabling the evaporation of organic solvents with high boiling points,
such as dimethyl sulfoxide (DMSO; boiling point, 189 °C). We have previously identified DMSO to be a good
candidate for drug loading into polymers using the swelling method, but have avoided it due to removal concerns.

Public health relevance
PROJECT NARRATIVE In this proposal, we request funding to support the purchase of a SP Genevac EZ-2.4 ELITE Evaporator System to support our work developing next-generation drug delivery systems using surface-eroding materials. Our Maximizing Investigators’ Research Award (MIRA) for Early Stage Investigators focuses on the synthesis of photo-responsive, surface-eroding materials and fabrication into 3D structures with the ability to predictably control release kinetics. A functional solvent evaporator is critical to the success of this research because it is used during all three stages of device preparation (polymer synthesis, fabrication, and drug loading).